Regulation of B cell Responses in SLE and Other Autoimmune Diseases

ADMINISTRATIVE CORE
ABSTRACT
The function of the Administrative Core will be to provide administrative support, governance, and efficient
management of this Autoimmunity Center of Excellence U19 with the overarching goal of ensuring the integrity
and scientific productivity of all projects. The Core will be directed by Dr. Iñaki Sanz (overall P.I. and Principal
Project).
The Administrative Core will provide the Projects and Cores with a review of all expenditures on a monthly
basis and will deal with University Accounting and Grants management offices concerning grant budgets. The
administrative support provided by the Administrative Core will reconcile all budgets of the Projects & Cores
and oversee compliance with safety and regulatory issues. In addition, the Administrative Core will be
responsible for organizing monthly face-to-face meetings. In all, this Core will ensure internal governance,
updated training and credentialing, patient safety and regulatory compliance.

Public health relevance
Project Narrative Not required for this component.